PHASE III SAFETY AND EFFICACY EVALUATION OF BETASERON IN MULTIPLE SCLEROSIS

The purpose of the study is to determine if the administration of Betaseron (interferon beta 1b) slows the progression of secondary-progressive multiple scleroris.